Mechanistic studies of the complex regulation of the signaling histidine kinase GacS from Pseudomonas aeruginosa

Structural and biochemical insights into the signaling mechanism of the histidine kinase
GacS from Pseudomonas aeruginosa
Project Summary
The nosocomial pathogen Pseudomonas aeruginosa causes acute and persistent,
chronic infections using distinct virulence mechanisms. The sensor signaling kinase GacS is a
major player in regulating these virulence mechanisms. GacS itself is regulated through a
complex set of non-canonical interactions. In recent work, our structural and biochemical studies
have revealed that RetS and GacS form a novel heterodimeric DHp-DHp domain interface but
that the overall GacS dimer remains intact. Consequently, GacS is predicted to undergo
substantial conformational changes to accommodate RetS. Here, we propose to test a novel
hypothesis positing that binding of the extracellular GacS ligand modulates RetS-GacS
interactions by controlling the rigidity of the protein. Under the first aim, we propose
experimentally validate the GacS kinking motion predicted by molecular dynamics simulations.
The second part of the aim will directly measure the impact of ligand binding on shape and
flexibility of a CitAGacS chimeric protein to test our hypothesis. Under aim 2 we seek to determine
the identity of the elusive GacS ligand and use virtual screening to identify drug-like modulators
of GacS. The in vitro screening approach is informed by our recent discovery of an inside-out
signaling mechanism, whereby RetS primes GacS for signal recognition. Virtual screening is
aided by the creation of a molecular model of the ligand-bound conformation of the sensory
domain.

Public health relevance
Project Narrative The bacterium Pseudomonas aeruginosa is a major cause of antibiotic resistant nosocomial infections and the leading cause of death for people with cystic fibrosis. Acute and chronic infection are regulated by distinct virulence mechanisms. We aim to determine how the interplay between the signaling kinases RetS and GacS controls the production of critical virulence mechanisms, in order to enable the development of new therapeutic options for the treatment of P.aeruginosa infections.